Polyamines and Hypusine in Type 1 Diabetes Pathogenesis

ABSTRACT
The pathogenesis of type 1 diabetes (T1D) involves complex intercellular interactions in the pancreatic
microenvironment, where endocrine, exocrine, and immune cells drive early inflammatory responses.
Macrophages are among the earliest immune cells to infiltrate the islets, initiating a dialog with β cells that
activates adaptive immune responses, promoting autoimmunity and β-cell loss. Our recent work identified
polyamines, small organic molecules involved in cellular growth and stress responses, and hypusine, a
polyamine-derived modification unique to the translation factor eIF5A, as critical regulators of mRNA translation
and inflammation in β cells. eIF5A requires hypusination for its activity and influences specific mRNA
translation linked to inflammatory pathways. As polyamine and hypusine biosyntheses can be modulated by
diet or small molecules, they offer real-world therapeutic targets to modify T1D progression. We hypothesize
that the polyamine biosynthetic pathway in early T1D orchestrates post-transcriptional inflammatory responses
in β cells. In the following Aims, this renewal application will leverage new findings, innovative animal models,
and cutting-edge technologies to test this overarching hypothesis:
Aim 1: Expose the pivotal role of β-cell ornithine decarboxylase (ODC) in the onset of T1D.
Aim 2: Decipher how hypusine modification shapes β-cell inflammation and drives T1D progression.
Aim 3: Reveal how β-cell polyamine metabolism modifies the inflammatory response in early T1D.
Whereas T1D is an autoimmune disease, therapies exclusively targeting the immune system have seen
variable success. Recent clinical successes using drugs that block inflammation and stress pathways more
broadly suggest a need to revise therapeutic approaches to T1D. Collectively, this study will significantly
advance our knowledge of how polyamine biosynthesis and hypusine modification scale inflammatory
responses, β-cell function, and survival in early T1D. Through these aims, we will uncover regulatory
pathways that could serve as novel therapeutic targets to preserve β-cell mass and function, addressing critical
gaps in current strategies for T1D prevention.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes is a disorder that results from a complex communication between β cells and cells of the immune system. Our prior work has shown that polyamines, small biogenic amines produced intracellularly, enables specific molecular responses in β cells to the immune assault seen in type 1 diabetes. This application proposes to study the enzymes and proteins that generate and metabolize polyamines in β cells and how these biogenic amines might be manipulated to alter disease progression in type 1 diabetes.